Autophagy and Pro-metastatic Differentiation

PROJECT SUMMARY
Autophagy is a tightly regulated intracellular degradation and recycling process crucial for cellular homeostasis
and adaptation to diverse cancer-relevant stresses. Because autophagy promotes the survival and metabolic
fitness of established tumors, there is great interest in targeting autophagy to treat cancer. Importantly, anti-
malarials, such as hydroxychloroquine (HCQ) are currently being repurposed as autophagy inhibitors in clinical
oncology trials. However, inhibiting autophagy also results in aberrant accumulation of autophagy cargo
receptors (ACRs), adaptor proteins that mediate the selective autophagic degradation of targets as well as
function as multidomain signaling hubs. The accumulation of ACRs supports oncogenic progression, drives
primary tumor growth and promotes therapeutic resistance in autophagy-deficient cells, but the role of ACRs
during metastasis has been less clear. In recently published data, we have demonstrated that the accumulation
of a specific ACR, called neighbor of BRCA1 (NBR1), promotes metastasis when autophagy is inhibited in tumor
cells. In mouse mammary cancer models, genetic autophagy inhibition promotes spontaneous metastasis by
enabling the outgrowth of disseminated tumor cells into overt macro-metastases. Furthermore, at both primary
and metastatic sites, genetic autophagy inhibition leads to the marked expansion of tumor cells exhibiting
aggressive and pro-metastatic basal epithelial differentiation, including the expression of cytokeratin 14 (CK14)
and the transcription factor p63. The upregulation of NBR1 in autophagy-deficient tumors is both necessary and
sufficient to promote metastatic outgrowth and pro-metastatic differentiation. Based on these findings, we
hypothesize that autophagy inhibition promotes the emergence of multiple aggressive tumor subpopulations due
to impaired NBR1 turnover. In aim 1, we will determine the mechanisms how NBR1 promotes basal epithelial
differentiation in carcinoma cells. In aim 2, we will evaluate the effect of autophagy inhibition on tumor recurrence
and intratumor heterogeneity. In aim 3, we will scrutinize how therapeutically modulating autophagy, both
positively or negatively, impacts metastatic differentiation via promoting the turnover or sequestration of NBR1.
Overall, this proposal will elucidate the mechanisms by which autophagy and NBR1 control aggressive
differentiation programs in breast cancer and how this regulation impacts recurrence and treatment response.

Public health relevance
PROJECT NARRATIVE By rigorously dissecting how the autophagy pathway suppresses metastatic outgrowth and pro-metastatic differentiation programs, this project will provide unique fundamental and timely insight into how to most effectively modulate autophagy to treat cancer patients, an issue of immense therapeutic significance.